Correlating Genotype and Phenotype of Metastatic Cancer Cells In Vivo Using Nanolaser Optical Barcode

Project Summary.
The complex dynamics of metastatic cancer, which include processes like plasticity, immune evasion, and
therapy resistance, pose significant challenges to effective treatment. While emerging single-cell
sequencing technologies now aid in understanding the genetic heterogeneity and clonality, as well as the
unique genome expression of individual cancer cells within tumor microenvironments, these methods often
fail to fully capture the behavior of living cells, such as migration, division, and regulation of volume and
mass. The primary technical bottleneck lies in the inability to read DNA barcodes in live cell states and the
limited number of unique fluorescence barcode colors available. Addressing these limitations is crucial for
enhancing our comprehension of metastatic cancer and improving treatment outcomes.
The proposed K25 project aims to develop a single-cell assay for correlating genome, transcriptome, and
dynamic behaviors of metastasis cancer cells in an in vivo mice model using laser particles (LPs). These
biocompatible particles emit ultrabright narrowband laser emission, creating unique optical barcodes for a
massive number of migrating cancer cells, enabling real-time tracking in vivo and compilation of data from
different assays. The project comprises three primary aims:
1. Employing LP to create workflows that correlate single cell sequencing with real-time observations of
cancer cell mass, volume, and migration using optical microscopy.
2. Creating multiplet LPs, multiple LPs within one body, to ensure the enduring uniqueness of barcodes for
long-term, in vivo tracking of cancer cells.
3. Integrating advancements to enable multidimensional single-cell assays within an in vivo metastatic
breast cancer model, linking migration and immune cell interaction data from imaging with single-cell DNA
and mRNA sequencing results.
The project's key innovations involve correlating the genotype and phenotype of migrating cells, integrating
cutting-edge LP technology into in vivo cancer studies, and analyzing high-dimensional single-cell data.
Aims 1 and 2 operate independently, while Aim 3 is designed to anticipate potential pitfalls and explore
alternative approaches. Each aim is supported by preliminary data. The project spans five years, focusing
on application to an in vivo model. Expected outcomes include successfully correlating genotype, genome
expression profile, and optical phenotypes with single-cell resolution, as well as uncovering novel insights
into tumor metastasis and therapeutic responses. Furthermore, the mentoring and training provided by the
advisory team empower the principal investigator of this project, with strong backgrounds in nanophotonics
and chemistry, not only to contribute significantly to cancer research but also to advance their career toward
independent academic positions.

Public health relevance
Project Narrative. Metastatic cancer continues to pose a significant challenge in oncology, requiring innovative strategies to comprehend its heterogeneity in living states. The proposed project seeks to create an in vivo single-cell assay for migrating cancer cells using laser particles (LPs) that emit narrowband emissions, enabling reliable and repeatable optical barcode readouts. Anticipated outcomes encompass successfully correlating genome, transcriptome, migration, and immune cell interaction with single cell resolution, conducting computational analyses of multidimensional datasets, and providing novel insights into tumor metastasis and therapeutic responses.